Resolving the spatial dynamics of single cell circadian regulatory networks

Project Summary/Abstract
Physiological and metabolic health relies on the circadian alignment of biological processes with the
environment. Since the first documented study of circadian rhythms in the 18th century using a plant system,
model organisms have been critical for defining the transcriptional mechanism of the oscillator and revealing the
importance of the clock on fitness. Most of this work is based on whole organism or organ level studies leaving
many mechanistic questions about how cell specific gene regulation leads to coordination of cellular clocks and
a concerted physiological response. We know that gene regulatory networks are effective at modeling gene
expression dynamics but resolving cell-type specific networks with time resolution remains a significant
challenge.
To delineate regulatory connections across cell-types, a single cell view is needed to develop network
models that reflect the true cell state rather than the variation among groups of cells or tissues. Only with these
cell specific networks can we begin to develop testable hypotheses about what regulatory variation underlies
physiological responses. This proposal describes a research strategy that leverages the genetic and molecular
power of the plant model system Arabidopsis thaliana and the latest single cell technologies to 1) Identify the
cell-types with distinct oscillators and their underlying regulatory networks, 2) Dissect how cell-type specific
circadian regulatory networks maintain a synchronized physiological response, and 3) Perturb cell-type specific
circadian gene regulatory networks and evaluate their physiological consequences.
Over the next five years, our goals are to delineate single cell circadian gene regulatory networks across
an entire organ with spatial resolution. Our Arabidopsis model system will be used to dissect how distinct cell
type specific circadian regulation controls a physiological response. Through perturbations to tissue specific
gene regulatory networks we will gain a better understanding of how cellular gene programming is coordinated.
Our long-term goal is to develop Arabidopsis into a model for understanding how cell specific gene regulatory
networks influence inter-tissue communication. This research will generate valuable insight into how we interpret
the influence of circadian gene regulatory variation on human health and the application of targeted therapies.

Public health relevance
Project Narrative The circadian clock helps to align metabolic and physiological processes with changes in the environment - dysfunction in these rhythms contributes to increased risk for cardiometabolic and neurodegenerative disorders. This proposal will use a model system to resolve how circadian regulation of gene expression at the cell level is coordinated across tissues to control a physiological response. This will be achieved by building cell specific models of circadian function to characterize how cellular variation in gene expression influences complex traits.